ISEH 52nd Annual Scientific Meeting

The International Society for Experimental Hematology’s (ISEH) 52nd Annual Scientific Meeting
will be held August 17-20, 2023 at the New York Marriott at the Brooklyn Bridge in New York,
USA. ISEH seeks support for young investigator attendance and participation in its 2023
scientific meeting.
Each year, ISEH hosts a one-of-a-kind meeting that features one day of pre-meeting workshops
for PhD students and postdoctoral fellows followed by three days of world-leading scientific talks
and networking activities. With activities geared towards students, postdoctoral fellows, junior
faculty, and senior faculty, we aim to provide resources and support for scientists at every level
of their career.
Our world-class scientific program blends a combination of invited speakers, oral abstract
presentations as well as poster presentations related to basic, translational and clinical
hematology. ISEH has a strong reputation for being a venue to share some of the best
unpublished research from around the world.
The size and setting of the ISEH meeting creates unmatchable networking opportunities
connecting young investigators with prestigious senior faculty to discuss research, techniques,
technology, publications, and career opportunities. Our approachable networking events and
opportunities to share research provide chances to impact a young investigators’ career
trajectory and growth in meaningful ways.
Our New Investigators and Junior PI Committees guide the development of these activities
targeted to junior (new) investigators, which is a critical differentiator of the ISEH meeting. In
2023, ISEH will host activities including a pre-meeting workshop, career development sessions
for PhD and Postdocs, a Junior Faculty forum discussion, a new technology session, a meet-
the-experts mixer, a Junior Faculty mixer, as well as featured poster presentations and oral
presentations. To support participation in the meeting, ISEH also has established a travel grant
program, in which young investigators can apply for funding to support meeting costs when
submitting an abstract.

Public health relevance
The International Society for Experimental Hematology’s (ISEH) Annual Scientific Meeting is an important forum for scientists at all levels to discuss and exchange original, unpublished research advancing the areas of hematology, hematologic disorders, stem cell biology, cell therapy and immuno-oncology in an inclusive, respectful, safe, and welcoming environment. The ISEH meeting is differentiated by its unparalleled opportunities for meaningful interaction, scientific debate, and mentorship of junior scientists around the world. The critical networking enabled at ISEH’s meeting advances the next generation of scientific leaders in experimental hematology, resulting in the translation of discoveries into drug development and critical therapies. Additionally, the ISEH meeting program features meaningful speaking opportunities for young investigators, resulting in what may be the first stage for a scientist to present high- quality research.